Cortical Dynamics and Neural/Behavioral Performance

What are the cellular and network cortical mechanisms of optimal neural and behavioral performance?
Through what mechanisms do spontaneous and evoked changes in the waking state of the cortex influence
sensory processing and behavior? The goal of my laboratory is to answer these broad and important questions
at levels extending from cellular and synaptic properties, to local circuits, to thalamocortical networks,
modulation, and behavior. Answering these questions are fundamental not only to understanding the normal
operation of the brain, but also its operation in a variety of disorders, from schizophrenia, to ADHD, autism, and
others. Our proposal is ambitious, but not unreasonable or unfocused. We have already made significant
progress towards a broad outline of important pieces of the puzzle, and therefore are confident that we will make
very significant progress towards a detailed clarification of these two fundamental questions during the funding
period.
More than a hundred years ago, two investigators, Yerkes and Dodson, noted that optimal performance
on difficult detection tasks was related to arousal level in an “inverted-U” shaped fashion. Increases from low
arousal to intermediate arousal would enhance performance on difficult tasks, while further increases in arousal
from intermediate to high would decrease performance. This result suggests that there is an “optimal state” for
both the brain and behavior. Surprisingly, until our recent study in behaving mice performing a difficult auditory
detection task, the cortical activity or circuit representation of optimal state had not been investigated. Our
investigation revealed that the optimal state for performance of a difficult auditory sensory detection task
occurred at intermediate levels of arousal and was associated with the suppression of slow corticocortical and
thalamocortical activity, a hyperpolarized and low variability of pyramidal cell membrane potential, and large
amplitude and highly reliable evoked auditory cortical synaptic responses. In an indication of the broad nature
of these effects, we observed that we could predict more than half of the variance in cortical neuronal membrane
potential, action potential, and even behavioral performance simply by measuring the pupil diameter – an easily
obtained measure of rapid (second to second) fluctuations in behavioral state. By explaining a large fraction of
neuronal and behavioral variance, we have demonstrated that the brain is much more precise and reliable than
previously thought. Here we propose to reveal the detailed cellular, modulatory, and network mechanisms that
account for these prominent effects of state variation on neural and behavioral performance. Through a
combination of state-of-the-art imaging, whole cell recording, optogenetic manipulation, and high quality
behavioral monitoring, we will be able to detail the contribution of multiple neuronal and neuromodulatory
pathways to the determination of optimal state for neural/behavioral responses.

Public health relevance
Narrative We have recently found that spontaneous variations in the waking state account for a substantial fraction of the variations in responsiveness of cortical neurons to sensory stimuli. We also found that sorting the animal's cortical sensory responses and behavioral choices by arousal state (as measured by pupil diameter) revealed an inverted U, with optimal responses and performance occurring at intermediate levels of arousal. Here we will address the cellular, network, and neuromodulatory mechanisms underlying the determination of optimal state for neural and behavioral performance. We hypothesize that neuromodulatory transmitter systems are in constant flux and that these fluctuations in release cause ongoing and influential changes in the operating properties of the cerebral cortex. We will use a variety of state-of-the-art techniques, including whole cell recording, two-photon imaging, and optogenetics, to reveal the precise cellular, network, and neuromodulatory mechanisms underlying rapid state control in awake, behaving mice. Dyscontrol of neuromodulatory transmitter release may underlie several different disease disorders. Understanding their mechanisms of function is critical to understanding both the ordered and disordered brain.